Neural Mechanisms of Social Information Processing

Project Summary
To feel, remember and act in a social environment, incoming social stimuli must be processed and represented.
Recent advances have revealed several routes of social information flow which converge on the dorsal (d)CA2.
Ensembles encoding individual identity have also been found in the dCA2, but how diverse social information is
integrated to form coherent social representations remains elusive. Studies in human participants have provided
early evidence that the hippocampus tracks two social features, familiarity and hierarchy, jointly. However, it is
poorly understood how neural ensembles encode social characteristics and how incoming information instruct
the formation of social representations based on those characteristics.
To address this major knowledge gap, our overall objective is to bridge circuit and population coding mechanisms
to determine the neural basis of social information processing. As familiarity and hierarchy are two factors by
which social relationships are evaluated across species, we reason that dissociating their circuit and population
coding mechanisms will reveal how social information is structured in the brain. Our preliminary data suggest
that the dCA2 is functionally relevant for hierarchy and familiarity behaviors and its activity scales with rank
distance. Given that the entorhinal cortex shows grid-like activity in rank representation, we hypothesize that the
dCA2 may display place cell-like dynamics to signal familiarity and hierarchy distance on an abstract social
cognitive map. We will test this hypothesis in Aim 1 with bulk (fiber photometry) and single-cell imaging
(Miniscope) of the dCA2 in response to varied familiarity or hierarchy stimuli. Using the imaging data, we will
evaluate predictive models of coding strategy with linear classifiers. In Aim 2 we will assess how social
presentations of familiarity and hierarchy arise. We have preliminary evidence that distinct neuromodulator
activity in the dCA2 correlates with rank distance. As neuromodulators are mainly released into the dCA2 by the
paraventricular nucleus of the hypothalamus (PVH), we hypothesize that specific neuromodulators released by
the PVH differentially impacts the geometry of the social characteristics. Thus, we will use novel neuromodulator
sensors to monitor their dynamics and manipulate their signaling during Miniscope recordings. Finally, we will
test their functional relevance by inhibiting their release from the PVH during hierarchy and familiarity behaviors.
The approach detailed in this proposal is highly innovative because it leverages new technological advances
(novel neuromodulator sensors) and integrates cutting-edge techniques (manipulation of neuromodulator
signaling with Miniscope imaging and computational modeling) to address a major knowledge gap in social
cognition. As no unified theories of circuit and population coding mechanisms for social information processing
exist, the proposed research is highly significant. A mechanistic understanding of how neuromodulatory inputs
regulate neural population coding will provide druggable targets, which have the potential to transform
therapeutic treatment of social cognitive deficiencies in neuropsychiatric disorders.

Public health relevance
Project Narrative Social information processing is essential for social learning, memory and decision-making, which are social cognitive behaviors impaired in several neuropsychiatric disorders. Dissociating the neurmodulatory, circuit, and population coding mechanisms of two social characteristics will reveal general principles underlying social information processing. As no unified understanding of circuit and population coding of social information exist, results from this proposal have the potential to transform our current understanding of social cognition.